Identifying the effects of NRF2 signaling on lung squamous cell carcinoma development

PROJECT SUMMARY:
The NRF2 transcription factor is mutated and activated in more than 30% of lung and upper aerodigestive
squamous cell carcinomas. NRF2 drives a gene expression program that mitigates oxidative and electrophilic
stress, reprograms and enables cancer cell metabolism, and suppresses lymphocyte infiltration. In lung
squamous cell carcinoma (LUSC) patients, NRF2 activity portends a poor prognosis and resistance to radiation
therapy, chemotherapy, and immune checkpoint inhibitors (ICI). Though frequently active in human cancers,
mouse models suggest that NRF2 mutational activation is not sufficient for oncogenesis—the temporal and
contextual underpinnings of how NRF2 contributes to cancer progression remain ill-defined.
This research proposal focuses on a major research objective of our laboratories: to understand the impact of
NRF2 activation in LUSC initiation and progression. To meet this goal, we have developed a novel genetically-
engineered mouse model (GEMM) to test the impact of an activated NRF2E79Q on LUSC incidence, and on tumor
histology, gene expression and metabolism. Because NRF2 activity correlates with resistance to ICI, our
proposed studies will also assess how NRF2 alters the tumor microenvironment (TIME) in LUSC. Thus, we meet
a research objective of PAR-22-216, “Development and early validation of in vivo or in vitro models for the
assessment of immunoprevention or immunotherapy efficacy”. Based upon our previous studies along with other
published reports, we hypothesize that NRF2 activation will increase LUSC incidence and progression,
while decreasing mouse survival and altering the TIME landscape. To test this hypothesis, we propose two
Specific Aims. In the first specific aim, we will define and understand NRF2’s oncogenic functions as a ‘second
hit’ in LUSC initiation and progression in our novel Rosa26LSL-Sox2-IRES-GFP;Nkx2-1fl/fl, LSL-Nrf2E79Q (SNN) GEMM.
In the second specific aim, we will assess the impact of NRF2 activation on TIME of LUSC developed in our
GEMM. We will characterize the incidence and pathology of LUSC arising in our GEMM along with overall
survival. We will apply state-of-the-art proteomics and mass spectrometry imaging to molecularly characterize
NRF2-wildtype and NRF2-mutant tumors. We will also comprehensively define changes in the composition of
pro- and anti-tumorigenic immune cell types and cell-intrinsic immunomodulatory molecules of the TIME using
high dimensional spectral flow cytometry, OIS-PRM proteomics, IHC, and transcriptomics. We will use the data
from this grant to support a subsequent R01 application identifying underlying mechanisms and therapeutic
targets for NRF2-active cancers and determine the efficacy of pharmacological agents to suppress NRF2 as well
as their abilities to sensitize LUSC to ICI therapy.

Public health relevance
PROJECT NARRATIVE Human lung squamous cell carcinomas remain one of the most common cancers worldwide with dismal prognoses and limited therapies. During the past eight years, we have focused on understanding how changes in the NFE2L2 (NRF2) signaling pathway in these cancers make them more aggressive with poorer patient survival. In this application, we will develop a new mouse model for lung squamous cell cancers to identify how NRF signaling changes the onset and growth of this cancer and alters the tumor’s response to immunotherapy treatments such as nivolumab (Opdivo) and pembrolizumab (Keytruda).